Tumor-barcoding coupled with high-throughput sequencing for quantitative radiogenomics of the abscopal response in NSCLC

Cancer immunotherapy (IMT) can produce robust and durable anti-tumor immune responses in some cases.
However, many cancers are non-responsive to IMT and combination approaches need to be actively
investigated, particularly in lethal tumors such as IMT-insensitive non-small cell lung cancer (NSCLC). Preclinical
studies in general have been found to be poor predictors of success for IMT agents and chemoradiotherapy
combinations in the clinic, likely due to poorly conceived and executed treatment protocols, dated disease model
systems and lack of an existing framework for cross-validation of preclinical results. There is a need to develop
a rigorous preclinical testing program for existing IMT agents combined with chemoradiation. NSCLC genetically
engineered mouse models (GEMMs) of the major molecular NSCLC subtypes have been created. However,
there are no NSCLC GEMMs that to our knowledge has demonstrated “abscopal” responses reliably to IMT,
which is one unique strength of this current proposal. Also, a major limitation of existing GEMMs is the relatively
small number of different genotypes that can be generated and their lack of quantitative precision. This proposal
leverages a new technique, tumor barcoding with barcode deep-sequencing (Tuba-seq) and in vivo Cre-lox and
CRISPR/Cre-mediated GEMMs to model oncogenesis and radiation-drug response with unprecedented
precision and genomic-comprehensiveness. We are using this R01 mechanism in the present proposal via two
Specific Aims stated below to test the following central hypotheses: (i) we hypothesize that treating with both
anti-PD-L1 and a novel orally bioavailable ATR inhibitor (ATRi), AZD6738, in combination with chemoradiation
will result in an improved and durable anti-tumor immune response in poorly immunogenic NSCLC GEMMs; and,
(ii) Tuba-seq we will allow an unprecedented view of the radio-pharmacogenetic landscape of NSCLC responses
in vivo. SPECIFIC AIM #1 – Establish a radio-pharmacogenetic map of oncogene-driven non-small cell lung
cancer to both chemoradiation and combined chemoradiation/anti-PD-L1 therapy We propose to use novel
CRISPR/Cre-mediated GEMMs of NSCLC to test the optimal combinations of chemoradiation with anti-PD-L1
IMT. We will then examine the mechanism of action of chemoradiation with IMT using multiparametric
immunologic approaches and an innovative technique enabling lineage tracing and direct quantification of
treatment effects on these different genetic backgrounds in vivo. SPECIFIC AIM #2 – Determine tumor cell
genotype effects on combination anti-PD-L1 immunotherapy and ATRi with chemoradiotherapy in oncogene-
driven non-small cell lung cancer. This Aim leverages our novel CRISPR/Cre-mediated GEMMs of NSCLC to
test genotype effects on the combination of anti-PD-L1 and ATRi with chemoradiation. By using all these tools,
we will be able to decode the major aspects of the molecular underpinnings of chemoradiation and combination
IMT resistance in NSCLC, contributing to improved therapies and positively impacting patient outcomes.

Public health relevance
PROJECT NARRATIVE The work we have proposed has a direct impact on the treatment of non-small cell lung cancer with chemoradiation and immunotherapy. As resistance mechanisms of chemoradiation with immunotherapy are not being intensely studied using relevant preclinical cancer models, our findings can have an immediate and large impact on the field. Lastly, the study of resistance mechanisms against chemoradiation with immunotherapy in lung cancer may allow a broader understanding of resistance mechanisms in other cancers and expose new pathways to target treatment resistance.